Community Outreach Core

ABSTRACT – COMMUNITY OUTREACH CORE
The goal of the Community Outreach Core (COC) is to continue supporting the Florida-California
Cancer Research, Education, and Engagement Health Equity (CaRE2) Center by sharing scientific
data and results from ongoing projects with throughout our communities, promoting clinical research
education, and training community members to be advocates and community influencers on cancer. Our
Community Outreach Core (COC) team has over 20 years of experience working in bicoastal community
engagement research, with diverse populations including but not limited to, Black, African American,
(B/AA) and Hispanic/Latinox (H/L) individuals of various country origins and of low socioeconomic status.
We will continue supporting Center investigators conducting prostate, pancreatic, and now, lung cancer
research. Building on COC’s prior work, four (4) aims to accomplish are to 1) Create and implement a
Community Advocacy Academy designed to train, support, and measure the impact of 600 community
advocates in sharing information about cancer, cancer research, and the CaRE2 Center and its projects
2) Develop and deliver to 5,000 community members evidence-based multimedia educational materials,
maximizing the use of technology and media, tailored to B/AA and H/L audiences, focusing on pancreatic
and lung cancer information, cancer research and clinical trials participation, and biospecimens donation
for cancer research. 3) Partner with CaRE2 investigators to host educational activities to inform and
educate B/AA and H/L diverse populations and other key stakeholders about cancer research advances
and CaRE2 center discoveries. 4) Partner with the CaRE2 Planning and Evaluation Core to evaluate the
effects of the COC program and activities.